The neural basis of touch and proprioreception in the primate orofacial sensorimotor cortex

PROJECT SUMMARY
There is a fundamental gap in understanding the cortical representations and integration of tactile and proprio-
ceptive sensations accompanying bodily movements in general and oromotor behavior in particular. This repre-
sents an important problem because until it is understood, the mechanisms underlying orofacial pain, sensorimo-
tor impairments, and sensorimotor integration will remain largely incomprehensible. The goal of the proposed
research is to dissociate the cortical representations of touch and proprioception during natural feeding behavior
by using an innovative sequence of nerve blocks together with multi-electrode array recordings and 3D tracking
of tongue and jaw movements in non-human primates. The tongue is a unique structure for investigating this
because it is in constant motion and assumes various postures when touching other oral structures (e.g., teeth,
palate, and gingiva) during feeding. More importantly, the tactile and proprioceptive afferent fibers innervating
the tongue enter the central nervous system separately in trigeminal (lingual nerve branch) and hypoglossal
cranial nerves, respectively. Such unique anatomy enables experimental dissociation of touch and propriocep-
tion. The central hypothesis is that tongue posture and contact with other oral structures are reflected in the
proprioception- and tactile-related responses of neurons in the primary somatosensory (SIo) and primary motor
(MIo) areas of the orofacial sensorimotor cortex (OSMcx). This hypothesis will be tested by pursuing three spe-
cific aims: (1) determine how information about tongue posture and contact with other oral structures is encoded
in MIo and SIo during natural feeding by eliminating tactile stimuli to the tongue and surrounding oral structures
through sequential nerve blocks to the maxillary and mandibular sensory branches of the trigeminal nerve, (2)
dissociate the neurons’ motor response from a proprioceptive response by using intracortical microstimulation
(ICMS) to evoke muscle twitches while tactile inputs to the tongue and other oral structures are blocked, and (3)
characterize the functional connectivity between tactile- and proprioceptive-related regions in OSMcx by spectral
coherence analysis and by the effects of low-intensity ICMS of a tactile region on a proprioceptive one and vice
versa. The proposed research uses an innovative approach that leverages the unique sensory innervation of the
oral region by different cranial nerves and integrates the simultaneous neural recording and tracking of the
tongue and jaw movements in 3D. The proposed research is significant because it will bridge the results of
decades of research on cortical representation of oral somatosensation and on the biomechanics of tongue/jaw
movements during oromotor behavior, thus filling an important gap in the field. The knowledge gained from this
work will lay the groundwork for future studies on oral somatosensation, pain mechanisms, and sensorimotor
integration. Ultimately such knowledge has the potential to inform the development of strategies for treatment of
sensory impairments associated with dental implants, trigeminal neuralgia, temporomandibular disorders, orofa-
cial pain, and for the restoration of sensory feedback for use in brain-machine interface.

Public health relevance
PROJECT NARRATIVE Oral somatosensation plays a key role in vital functions of breathing, feeding, and speech such that altered sensation in pain disorders and sensory loss following neurological injuries have devastating effects on the quality of life. The project will provide novel insights on separate representations and integration of tactile and proprioceptive sensations in the brain during natural oromotor behavior and will lay the groundwork for future studies on oral somatosensation, pain mechanisms, and sensorimotor integration. It will inform the development of strategies for the evaluation and treatment of sensory impairments associated with dental implants and nerve injuries, trigeminal neuropathies, temporomandibular disorders, chronic pain, oromandibular dystonia, sensorimotor disorders, and for the restoration of sensory feedback for use in brain-machine interfaces.